IMAGING CORE

IMAGING CORE
SUMMARY
The Imaging Core provides CVS faculty and their students with access to specialized equipment
as well as highly trained technical staff for research that involves histology, human and animal
imaging and adaptive optics facilities that support corneal and retinal imaging as well as
psychophysics. There are three components of the Imaging Core. The Histology/Microscopy
Facility supports harvesting, tissue preparation and microscopic examination of visual system
tissue. A present goal is to query CVS members about histological methods they need for their
research, particularly those they need assistance with. Dr. Michael Telias and his new
technician Sarah Farid, will support the efforts of CVS members to perform challenging methods
they do not have experience with, such as in situ hybridization and a wide variety of antibody
methods. The Clinical Imaging Facility, supervised by Rachel Hollar, an imaging specialist
with over 10 years of experience, gathers a wide variety of images including Spectralis, fundus
images, optical coherence tomography, etc. on humans and animals. The Adaptive Optics
(AO) Facility provides experienced staff, supervised by David Fernandez, that help with the
design, construction and maintenance of AO systems for retinal and anterior segment imaging
of human, macaque and mouse.